Rapid Identification and Quantification of Organisms from Heterogeneous DNA

DESCRIPTION (provided by applicant): The specific objective of this proposal is to create a method for quickly identifying the species composition of organisms present in high-throughput DNA sequencing data. The main hypothesis is that every organism has a unique k-mer frequency vector that can be constructed from the organism's genome to quickly identify the organism in heterogeneous DNA sequencing samples using methods from linear algebra and statistics. The goals of this research are to build a computational framework for storing and manipulating k-mer frequency vectors, develop a regression model for identifying organisms and estimating their abundance from heterogeneous, short-read DNA sequencing samples, and apply this method for city-wide pathogen detection as part of the New York City PathoMap project.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project is relevant to public health as the results will be useful in research efforts where a clear understanding of species composition in complex microbial communities is needed such as those that pose potential pathogenic threats to humans that interact with these communities. In addition, much research is focused on investigating the role that microbial organisms play in regulating health and disease inside the human body. These microbiome studies can be better facilitated with the development of accurate and efficient computational methods such as the one presented in this proposal.